Disecting the cognitive Role of Hippocampus Administrative Supplement

Project Summary/Abstract – A Project Summary/Abstract is not necessary for this Administrative Supplement

Public health relevance
Project Narrative – A Project Narrative is not necessary for this Administrative Supplement